Mechanisms of sensory neuron morphological diversification, signaling, and functional plasticity

PROJECT SUMMARY
The overall goal of our NIGMS-funded research program is to identify and characterize the mechanisms that
allow individual sensory neurons to sense and respond to defined environmental cues, and to modulate these
responses based on experience and context. The lab explores these issues in two independent but related
areas. In the first, we study how individual sensory neuron types acquire their specialized sensory cilia
morphologies. In the second, we study how the morphologies and functions of sensory neurons are modulated
by experience. With R35 funding, we have been able to build synergies between these research areas and to
extend our work in unanticipated directions. A first major goal for the upcoming period will be to build on our
work in ciliogenic mechanisms to investigate how the organization of neuronal cilia within a sense organ, as
well as interciliary contacts, contribute to shaping sensory neuron functions. We previously showed that
sensory cilia are stereotypically organized within a head sense organ in C. elegans; the mechanisms that
underlie this organization and the functional consequences of this patterning are unknown. We will determine
whether an adhesion code regulates interciliary contacts and organization, and explore how these contacts
regulate neuronal communication and function. A second major goal will be to investigate how temperature
experience reshapes the complex morphologies of the AFD thermosensory neuron pair in C. elegans. The
architecture of the AFD sensory endings is regulated by neuronal activity and plays a critical role in the ability
of these neurons to adapt and respond to environmental temperature variations. We will exploit our expertise in
neuronal cell biology and high-resolution analyses of sensory behaviors and sensory neuron responses to
describe how the shape of the AFD sensory endings is modified as a function of the animal’s experience, and
how this modification in turn modulates AFD function. A third major goal will be to investigate how the
experience of an analog variable such as temperature is translated into graded gene expression changes in a
single sensory neuron type in vivo, and how these gene expression changes in turn influence neuronal
properties. We plan to establish whether the gene expression pattern in a neuron encodes its temporal activity
history, identify the required regulatory mechanisms, and assess the consequences on neuronal functions. Our
multifaceted experimental approach will allow us to generate a comprehensive description of how activity and
experience intersect with developmental pathways to modify sensory neuron structure and function, thereby
generating appropriate behavioral plasticity. This award will also enable us to continue to train the next
generation of scientists, to establish new collaborations, and to generate and test innovative and novel
hypotheses. Given the conservation of sensory and ciliogenic mechanisms, we expect that findings from this
work will be broadly generalizable, and may provide insights into how altered regulation of neuronal structural
and functional plasticity leads to disease.

Public health relevance
PROJECT NARRATIVE / PUBLIC HEALTH RELEVANCE Sensory neurons allow animals to detect and identify constantly changing environmental cues in order to make the appropriate behavioral and developmental decisions. Defects in the ability to correctly sense and process external signals lead to neurodevelopmental, behavioral, and cognitive disorders. This proposal uses the simple nervous system of the nematode C. elegans to explore how sensory neurons acquire and modify their specialized structures and functions, and how defects in these processes lead to disease.